Uncleaved prefusion-optimized trimers on nanoparticles as HIV vaccines

Project Summary
The envelope glycoprotein (Env) of human immunodeficiency virus type 1 (HIV-1) harbors the epitopes of broadly
neutralizing antibodies (bNAbs) and is the main target of HIV-1 vaccine development. High-resolution structures
of BG505 SOSIP.664 trimers have provided a rational basis for vaccine design. Although current gp140 designs
can produce native-like trimers for selected strains after optimization, the underlying causes of Env metastability
are still unknown and a general design platform applicable to all HIV-1 strains and subtypes remains an unmet
challenge. Furthermore, despite the increasing appreciation for the advantages of virus-like particles (VLPs) in
bNAb elicitation, nanoparticulate display of native-like trimers has not been rigorously explored in HIV-1 vaccine
development. In this R01, we will develop HIV-1 vaccine candidates by combining trimer design, crystallography,
electron microscopy (EM), nanoparticle display, immunization, serological assays, antibody isolation, repertoire
sequencing, and antibody lineage analysis. In Aim 1, we will investigate the fundamental causes of HIV-1 Env
metastability and develop the uncleaved, prefusion-optimized (UFO) trimer platform. We hypothesize that gp41,
which contains a structurally strained heptad repeat 1 (HR1) with a disordered N-terminal bend (N-HR1), is the
source of metastability. We have designed 1st-generation UFO trimers with a modified N-HR1 and solved their
structures. We will develop an optimized UFO platform applicable to diverse Envs with high purity, yield, and
stability and select representative UFO trimers for vaccine development. We will assess trimer antigenicity using
a panel of bNAbs and non-NAbs and determine their atomic structures. In Aim 2, we will engineer stable gp140
trimer-presenting nanoparticles as vaccine candidates. We hypothesize that self-assembling nanoparticles with
underlying 3-fold axes can be used to display native-like gp140 trimers. We have reported gp140 nanoparticles
based on the 24-mer ferritin (12 nm) and 60-mer E2p (23nm). We will optimize UFO gp140 nanoparticles based
on ferritin, E2p, and a hyperstable 60-mer, I3-01 (25nm) for in vivo testing in Aim 3. We will validate nanoparticle
assembly by EM and evaluate nanoparticle antigenicity using a panel of antibodies. In Aim 3, we will assess the
immunogenicity and B-cell response for a subset of optimized UFO trimers and nanoparticles in WT mice, rabbits,
and nonhuman primates (NHPs). We hypothesize that UFO trimers can induce tier-2 NAbs in all animal models,
while gp140 nanoparticles displaying 8-20 UFO trimers can elicit tier-2 NAbs more effectively than trimers alone.
We will first screen UFO trimers and nanoparticles in WT mice and assess serum neutralization using purified
IgGs. We will select a small set of immunogens for rabbit immunization and advance the most promising ones
to NHPs. In our preliminary study, gp140 nanoparticles induced autologous tier-2 NAbs to BG505.T332N in mice
and rabbits within 6-8 weeks, supporting our approach. We will isolate vaccine-elicited tier-2 NAbs for functional
and structural studies and perform next-generation sequencing (NGS) to study B-cell repertoires and trace NAb
lineage development. Our goal is to identify the most effective vaccine candidates for future clinical studies.

Public health relevance
Narrative Native-like trimers provide a promising platform for HIV-1 vaccine design. In this R01 project, we investigate the fundamental causes of HIV-1 Env metastability, develop and optimize the uncleaved, prefusion-optimized (UFO) trimer platform, and display UFO trimers of selected subtypes on self-assembling nanoparticles. After structural and antigenic evaluation, we assess the immunogenicity and B-cell response for a subset of UFO trimers and nanoparticles first in WT mice and rabbits and then in NHPs to identify the most effective vaccine candidates.